Pulmonary Focused Foundations in Innovation and Scholarship (PuFFInS)

PROJECT SUMMARY
This is a new application seeking T32 grant support for a postdoctoral research training program in basic
research, translational research, clinical research, clinical trials and health service research relevant to improving
lung health within the southeastern United States. The ultimate goal of the Pulmonary Focused Foundations in
Innovation and Scholarship (Puffins) Training Program is to recruit, train and ensure that the next generation of
investigators have the skillsets needed to improve the healthcare and outcomes for individuals with lung diseases
with particular emphasis on lung cancer prevention, screening and implementation, critical care, and rare lung
diseases, including pulmonary fibrosis, sarcoidosis and cystic fibrosis. Our interactive and interdisciplinary
Puffins Training Program brings together a spectrum of well-­funded investigators across the Medical University
of South Carolina, including clinician researchers, epidemiologists, and cell biologists. The training program is
structured to help Fellows obtain the necessary competencies and expertise for sustained careers in pulmonary
medicine in a flexible framework that accommodates a diverse range of prior education/experience. Puffins
Fellows may matriculate into one of two research tracks with a foundation in innovation and entrepreneurship:
Clinical Science Research Track focused on clinical trials and health service research and Basic Science
Research Track. Training will be outlined in each Fellow’s Individualized Development Plan and guided by their
selection of a Primary Mentor in a pulmonary-­related research area and Secondary Mentor to provide a
complimentary interdisciplinary scientific approach or clinical area of expertise. Puffins Fellows will also benefit
from core and selective training options that include formal course work, workshops, training in the responsible
conduct of research, and retreats. The application requests support for 2 Puffins Fellows in year 1, and 4 Fellows
in years 2-­5. Puffins Fellows will be on the research training grant for two years. The Program Steering
Committee will review and approve the selection and annual re-­appointment of Puffins Fellows based on
specified criteria and evaluation data. A multi-­year assessment plan will be used to: 1) assess each Fellow’s
performance and experience in the program and subsequent development and productivity;; 2) assess the
effectiveness of the mentors and mentee-­mentor relationships;; 3) enable program leadership to determine if the
objectives of the program are being achieved;; and 4) inform strategic direction for future program development.

Public health relevance
PROJECT NARRATIVE There is an urgent, unmet public health need to improve outcomes for chronic lung diseases, which disproportionately impacts the Southeast. This program will provide research training for investigators who will ultimately improve the healthcare and outcomes for individuals with lung diseases with particular emphasis on lung cancer prevention, screening and implementation, critical care, and rare lung diseases, including pulmonary fibrosis, sarcoidosis and cystic fibrosis. Training in innovation and entrepreneurship will enable investigators to create innovative solutions to challenges in health, to catalyze interdisciplinary entrepreneurial efforts, and ultimately become change agents to address national and global health problems.